Single-cell Multi-omic Profiling of Drug Responses Using Pooled iPSC-CM Differentiation

PROJECT SUMMARY
Cardiovascular complications of cancer therapy significantly contribute to the global burden of cardiovascular
diseases. Although remarkable progress has been made in understanding the genetic basis of doxorubicin-
induced cardiotoxicity (DIC), we cannot predict which patients will be affected by DIC or protect patients at risk
for suffering from DIC adequately. Here, we will use a novel multiplexing methodology of creating a "cell village"
by pooling multiple patients' induced pluripotent stem cell (iPSC) lines in a dish to map the genetic basis of inter-
individual differences in response to doxorubicin. In Aim 1, we will co-culture 100 iPSC lines in 10 distinct "cell
villages," where each "cell village" contains ten independent patient-specific iPSC lines. Next, we will differentiate
each "cell village" into iPSC-derived cardiomyocytes (iPSC-CMs). Finally, we will perform a single-cell multi-
omics sequencing analysis of the "cell villages" to understand the impact of genetic variability on cardiomyocyte
gene regulation and functions at baseline. In Aim 2, we will employ a single-cell multi-omic approach to uncover
and validate the role of response eQTL in DIC prediction. We will treat iPSC-CMs in each "cell village" with
doxorubicin at various doses. Next, we will perform single-cell multi-omics profiling to model the contribution of
genetics to variability in responses to doxorubicin treatment. In Aim 3, we will employ 3D engineered heart tissues
(EHTs) and CRISPR/cas9 genome-editing to comprehensively study the functional role of two candidate
doxorubicin response genes. All in all, the proposed experiments will serve as a proof-of- principle in using the
"cell village" model as a high throughput personalized drug screening platform.

Public health relevance
PROJECT NARRATIVE Cardiovascular toxicity presents a significant problem for cancer therapy, as the adverse effects often interfere with the treatments and compromise patients' long-term survival. This proposal will interrogate the interplay between genetic variants in the etiology of doxorubicin-induced cardiotoxicity by employing the iPSC-CM “cell village” platform coupled with engineered heart tissue, scRNA-seq, scATAC-seq, and CRISPR/Cas9 genome editing technologies. The knowledge we collect here with the “cell village” model should be instrumental in interrogating interindividual susceptibility at a large-scale and high throughput fashion.